Training Program in the Biology of Aging and Lung Diseases

The lung is a major determinant of human health and respiratory diseases are a leading cause of morbidity and
mortality among the elderly. The elderly population is one of the fastest-growing demographics in the US and
worldwide. Our innovative T32 program in Biology of Aging and Pulmonary Diseases addresses a critical need
to train biomedical researchers, physician scientists and future leaders in the links between aging and lung
disease. We propose a multidisciplinary training program that will integrate basic mechanistic investigation of
pulmonary disease and the biology of aging, with translational and clinical investigation of acute and chronic lung
disease. The Division of Pulmonary, Critical Care and Sleep Medicine (PCCS) at The Ohio State University has
been in a growth phase with the influx of investigators with well-recognized research programs and established
track records of training. This new training program will be co-directed by Ana L Mora, MD, the Associate Director
of research in the Davis Heart and Lung Research Institute and Rama Mallampalli, MD, the Chair of the
Department of Internal Medicine (DOIM). An Executive Committee comprised of Jeffrey Horowitz, MD, Division
Director of PCCS, and Mauricio Rojas, MD, Associate Vice-Chair of Research in the DOIM will support Drs. Mora
and Mallampalli in the administration of the training program. Five total positions will be available for MD and
PhD scientists, with a 3-year structured, milestone-driven curriculum based primarily in laboratory research and
complemented with research and career development retreats, translational core competencies, seminars, an
academic survival skill conference series, workshops, and grant writing workshops. Our training plan is
structured around individualized development plans that emphasize quantifiable outcomes including
publications, career development awards, didactic courses and transition to research and academic careers. A
dual mentorship training design will give trainees essential cross-disciplinary scientific and professional guidance
in 6 areas: 1) Aging, Senescence and Metabolism, 2) Immunity and Host Defense, 3) Injury and Repair, 4)
Environmental Exposures, 5) Therapeutics and Transplant, and 6) Biomedical Informatics. OSU’s environment
for pulmonary training is unparalleled, with faculty in the Department of Internal Medicine-Division of Pulmonary
Critical Care and Sleep Medicine, Department of Microbial Infection and Immunity, Department of Physiology
and Cell Biology, Department of Surgery, Department of Biomedical Informatics, Department of Biological
Chemistry and Pharmacology, Department of Pediatrics, Department of Molecular Genetics, Department of
Chemistry and Biochemistry, and the Davis Heart and Lung Research Institute engaged in NHLBI-funded
research across basic, translational, and clinical disciplines. This faculty, infrastructure, leadership, trainee pool,
and unique scientific focus will address a critical pulmonary field and build a training program with emphasis in
diversity. OSU is deeply committed to training underrepresented racial and ethnic groups for academic careers
as is shown recruiting female and underrepresented trainees, staff and faculty.

Public health relevance
PROJECT NARRATIVE The aging population is increasing at an unprecedented rate at the US and worldwide. Aging impacts the severity and susceptibility of acute and chronic lung disease, however the mechanisms responsible for cellular aging and age-related susceptibility to disease are complex and incompletely understood. This integrated and multidisciplinary training program provides critical and structured guidance for postdoctoral trainees who will be at the forefront advances in biology of aging and pulmonary science.